Core-001

ABSTRACT
The University of Chicago Medicine Comprehensive Cancer Center (UCCCC) integrates and centralizes
cancer-focused educational and professional development activities across the University of Chicago. The
UCCCC actively supports the training and career development of the next-generation of cancer researchers.
The programming and activities of the UCCCC Cancer Research Career Enhancement and Related Activities
Core engage trainees at all levels (high school, undergraduate, graduate/medical student, postdoctoral, faculty,
and healthcare professionals in our community), especially those from populations underrepresented in the
biomedical sciences and cancer research. This is especially important in the communities that we serve on the
South Side of Chicago. Our long-term goal is to innovate in the development and integration of career
enhancement activities for trainees to support their cancer-focused career success and the development of a
robust and diverse cancer research workforce. We accomplish this goal with the following Specific Aims: 1) To
provide pipeline programming for high school and undergraduate students to encourage students, including
those from backgrounds underrepresented in the biomedical sciences, to explore careers in cancer research
and/or medicine; 2) To provide integrated, multidisciplinary cancer research training opportunities for graduate
students, combined MD/PhD trainees, and medical students; 3) To provide career enhancement activities for
postgraduate fellows and faculty at all levels; and 4) To provide professional development activities for
community partners, including healthcare professionals. The UCCCC serves as the coordinating body for
activities of cancer-based training and mentoring programs at all levels across the University of Chicago
Medicine and Biological Sciences Division (BSD), leveraging existing infrastructure and addressing training
gaps. Specific strengths and unique aspects of this Core are: 1) A multifaceted approach to support aspiring
and established researchers across their career trajectory; 2) Strong partnerships among key institutions on
Chicago’s South Side, including institutions of higher learning and diverse high schools; and 3) An exceptional
leadership and mentoring team of highly dedicated, passionate, and experienced individuals to execute the
programs.